Trimming of Amyloid Peptides by Gamma-Secretase

DESCRIPTION (provided by applicant): The amyloid -protein (Aβ), strongly implicated in the pathogenesis of Alzheimer's disease (AD), is formed by the sequential cleavage of the amyloid -protein precursor (APP) by β- and γ-secretases. γ-Secretases cleaves the APP transmembrane domain at the γ site, producing the C-terminus of Aβ, and at the ε site, producing the N-terminus of the APP intracellular domain. The goal of this project is to understand the process by which the γ--secretase complex trims long Aβ peptide intermediates into shorter forms and how disease- causing PS mutations alter activity. With these goals in mind, the following specific questions will be addressed: (1) Which shorter Aβ peptides are produced via the trimming of specific long Aβ peptides? We will identify and quantify all Aβ peptides formed from normal ε cleavage products Aβ49 and Aβ48. We will also determine if Aβ50, which is not a ε normal cleavage product, leads to the formation of the otherwise unobserved Aβ47, Aβ44 and Aβ41. The result will help answer the question of whether trimming by every 3 residues is a general rule, and if so, how rigid is this rule. (2) How does γ-secretase accomplish C-terminal tripeptide trimming of long Aβ peptide intermediates? Evidence supports initial ε proteolysis to produce long Aβ peptides and then cleavage every 3 residues, but the mechanism by which this occurs is unknown. We hypothesize that the newly formed carboxy-terminus of long Aβ produced upon ε cleavage by γ-secretase is critical for trimming and with apparent precision by every 3 residues. To test this hypothesis, we will examine the ability of C-terminal amides of long Aβ peptides to serve as substrates. (3) What are the effects of Alzheimer-causing PS1 mutations on the trimming of long Aβ peptides? We have shown that such PS1-mutant γ-secretases complexes can increase the proportion of long-to-short Aβ peptides from recombinant APP substrate. Here, we will test the conversion of Aβ49 and Aβ48 by these mutant protease complexes, examining the Aβ products that are formed, the proportion of these products, and their rates of formation relative to the wild-type complex. We hypothesize that the disease-causing PS1 mutations increase the proportion of long Aβ peptides by slowing down the trimming process in general.

Public health relevance
PUBLIC HEALTH RELEVANCE: The goal of this project is to understand γ-secretase, a complex enzyme critical to the cause of Alzheimer's disease. Biochemical experiments are proposed to test hypotheses about how this enzyme works and how it is dysregulated in Alzheimer's disease.